Learning Science Through Research

Project Summary
Science is best learned by doing what scientists do, especially in performing authentic scientific
investigations where the unknowns are many, the design to experimentally explore the unknowns is complex,
the instruments and expertise to execute the experiment(s) are advanced, and a highly skilled and informed
mentor is critical. The New Hampshire Academy of Science (NHAS) believes that the pursuit of scientific
investigations that contribute to scientific understanding and inspire the pursuit of STEM careers should be
available to all students. In our northern area of NH and VT, opportunities for pre-college students to perform
meaningful and inspiring scientific research with teachers as effective science mentors are extremely limited or
non-existent. The NHAS intends to help resolve these limited opportunities by using its advanced STEM Lab
and its connections with mentors in our scientific community to greatly expand its support of middle and high
school students and their teachers in experiencing discovery-based science. The NHAS has established a well-
equipped primary satellite STEM laboratory at the Fairbanks Museum and Planetarium (FMP) that has a close
relationship with the economically depressed rural north of VT in order to advance the museum’s science
programs and offer students experiences in inquiry-based research. The NHAS will also establish a primary site
at Colby Sawyer College (CSC) that will make the design and execution of research-based activities part of the
learning experience of future biology/science teachers at CSC with IDeA Network of Biomedical Research
Excellence (INBRE) support. CSC will also function as a geographically strategic location for outreach to
secondary schools in the rural center of NH. A small number of more modest secondary satellite laboratories will
be established in regional schools for students to perform research that matches their abilities and interests.
Teachers will be provided professional development in the day-to-day practices of professional scientists to
transform those teachers into inspirational mentors for their students. This will influence these teachers and their
peers to performing inquiry-based science investigations in their respective schools. A web-based system will
provide peer-to-peer student, teacher, and mentor platforms to ensure that students and teachers have the
constant intellectual and personal support that they need for career advancement. There will be multiple
opportunities for students and teachers to present their research at regional and national science events
including the annual meeting of the American Association for the Advancement of Science. Parents will be
encouraged to attend these events as well as more local conferences to help them appreciate the opportunities
in STEM careers for their children. This long-term mentoring support for students and teachers on both personal
and intellectual levels serves a critical need for attracting and retaining underserved students into science and
health careers. With this grant, the STEM Labs of the NHAS, FMP, and resources at CSC will create a vibrant
scientific community in the region, where students, teachers, and parents have a shared and enduring role.

Public health relevance
Project Narrative The Learning Science Through Research program (LSTR) employs the scientific and educational resources of the New Hampshire Academy of Science (NHAS), the Fairbanks Museum and Planetarium (FMP), and Colby Sawyer College (CSC) in providing authentic STEM research experiences to students, their teachers, and prospective teachers from underserved rural communities. By fully involving parents, teachers, and students, the program will: 1) inform all parties to the broad and growing opportunities in health and science careers, 2) transform middle/high school science teachers into inspirational mentors and educational leaders, 3) enable students to carry out the practices of designing, executing and publishing scientific research, 4) enable teachers and students to access peer-to-peer support as well as the mentorship of experienced STEM professionals from regional STEM corporations to become ethical and productive scientists, and 5) advance the STEM career development of underserved students.